Implementation Laboratory

PROJECT SUMMARY – Implementation Laboratory
Background and vision. As an Advanced Center, the vision of the Washington University Implementation
Science Center for Cancer Control (WU-ISCCC) is to conduct implementation research to help eliminate
cancer disparities in rural and other disadvantaged communities.
Goal. The Implementation Lab, hereafter called the Innovation Incubator, through Incubator Membership, a
Data Management Unit, and a Practice Surveillance Unit, will work closely with the WU-ISCCC Research
Program to facilitate implementation science research by connecting investigators to implementation sites in
the Membership, convening community and clinical partners to review data and identify needs and priorities,
and support evaluation of program outcomes.
Aims. The Incubator will:
Aim 1. Establish leadership structure and functions that enable and support rapid-cycle and innovative
implementation science in cancer control.
Aim 2. Sustain and develop additional research partnerships with a range of healthcare systems and
organizations/agencies committed to innovative implementation science projects that address social
determinants of health and reduce cancer disparities.
Aim 3. Support data systems and resources to manage multi-site projects, collect rigorous data, and produce
timely reports to the project leaders and the WU-ISCCC leadership.
Aim 4. Cultivate a surveillance unit to report on progress toward reducing cancer disparities in the populations
across Siteman Cancer Center's 82-county catchment area.
Aim 5. Draw on real-time clinical service data from health systems within BJC Healthcare and the BJC
Collaborative network to monitor policies, provider practices, patient outcomes and progress in
reducing cancer disparities.
Innovations and impact. The Incubator will work to fulfill the overall goal of the WU-ISCCC to build a rigorous,
scientific evidence base for rapid-cycle implementation research to increase the reach, external validity, and
sustainment of effective cancer control interventions. We will convene multi-sector partners to inform and act
as settings for innovative and impactful research prioritizing rural and other underserved communities. The
Incubator will provide statistical and data support for rigorous execution of pilot and methods studies coming
out of the Research Program, supporting investigators from conceptualization and planning through
dissemination. These linkages and activities of the Incubator and our diverse Membership will position the WU-
ISCCC to accelerate the innovation, pace, and impact of implementation science for cancer control and
reduce cancer health disparities in our region and nationwide.